Understanding the Role of Alzheimer’s Disease Pathology in Mild Behavioral Impairment

Project Summary
An estimated 6.7 million US adults live with Alzheimer’s disease (AD) and related dementias (ADRD); a figure
that is expected to more than double by 2060 unless new prevention strategies or treatments emerge.
Although later-life neuropsychiatric symptoms have been associated with a greater risk of dementia, they are
all too often viewed and treated as independent of ADRD. This traditional approach overlooks the possibility
that neuropsychiatric symptoms emerge as pathology accumulates in brain regions or networks that differ from
those affected by the more common “memory first” phenotype. Thus, the proposed project leverages a recently
developed mild behavioral impairment (MBI) diagnostic framework that standardizes the assessment of
neuropsychiatric symptoms in older adults during the pre-dementia phase(s). MBI is not equivalent to mild
cognitive impairment (MCI), but a “complementary behavioral analog” to MCI. While MBI is typically linked with
regional atrophy of the medial temporal lobes, this is likely an over simplistic approach that fails to distinguish
between MCI and MBI. Thus, our central hypothesis is that MBI arises from a network-level impact of AD
pathology on the neural circuitry primarily implicated in the processing and integration of emotional experience
- i.e., the salience and default-mode networks.
To test this, we will investigate the network-level structure-function relations associated with MBI (Aim 1) and
assess blood-based AD biomarkers’ association with MBI symptoms and network-level indices of
neurodegeneration (Aim 2) using data from a well-characterized longitudinal cohort of over 690 individuals of
the NIA P30-funded Michigan Alzheimer’s Disease Research Center. We will then perform an open-label pilot
study to test the effect of network-level neuromodulation on MBI using high-definition transcranial direct current
stimulation (HD-tDCS) in those with MBI (Aim 3). The proposed project integrates and directly complements
my training plan to address a critical gap in understanding why those with MBI are at risk for conversion to
dementia. This is the first study to integrate blood-based biomarkers with network-level correlates of MBI and
propose a network-based individualized neuromodulation-based intervention in those with MBI. This study will
advance our understanding of network-level patterns of brain atrophy, changes in functional connectivity, and
accumulating AD pathology, thereby further validating MBI as a novel marker of preclinical AD. The project
also translates gained knowledge into actionable treatment plans for those with MBI by testing individualized
HD-tDCS to mitigate network level dysfunction. The combination of these findings and the novel skills
developed through my training plan are vital for a future R01 as an independent investigator that will examine
the effects of HD-tDCS on emotional processing in those with MBI.

Public health relevance
Project Narrative The proposed project will assess mild behavioral impairment (MBI) as a potential early indicator of dementia rather than an isolated condition. By investigating the relationship between MBI, neural network function, and blood-based AD biomarkers, the study aims to help validate MBI as a novel marker of preclinical AD, enabling early detection and timely interventions to delay dementia onset and enhance quality of life. Furthermore, the pioneering use of high-definition transcranial direct current stimulation (HD-tDCS) to enhance brain function in those with MBI could revolutionize treatment strategies, directly translating our enhanced understanding into practical interventions to improve the lives of millions affected by AD.